Massachusetts Center for Alzheimer and dEmeNtia behaVIoral reSearch In minOrity agiNg (Mass-ENVISION)

Massachusetts Center for Alzheimer and dEmeNtia behaVIoral reSearch In minority agiNg (Mass-ENVISION) is a proposed new Alzheimer's-related RCMAR that will address the critical need for mentored research training for scientists in the development, testing, and implementation of behavioral interventions across hospital and community settings, for older adults with Alzheimer’s Disease and Related Disorders (ADRD) and their informal care partners, including those affected by health disparities under the NIA framework. There is a dearth of evidence-based behavioral interventions to support older persons with ADRD, their informal care partners, and dyads, as well as a critical gap in the number of scientists poised to mitigate this geriatric care shortage. To address these research and resource gaps, Mass-ENVISION will identify scientists who are committed to ADRD behavioral health and interventions research and will support training and development of independent scientists poised to eliminate health disparities under the NIA framework in ADRD behavioral health. Further, Mass-ENVISION would become the only RCMAR to serve the entire New England region, which is in critical need of this resource. Mass-ENVISION, a collaboration of Massachusetts General Hospital (MGH), Boston University (BU) and Cambridge Health Alliance and their medical school affiliations (Harvard Medical School, BU School of Medicine), university-affiliated hospitals, other Boston and MA- area research centers, satellite hospitals and community clinics, will provide RCMAR Scientists with interdisciplinary, comprehensive training and sustained and tailored mentoring in ADRD behavioral health and interventions research using the revised NIH Stage Model, the Science of Behavior Change, prevention approaches under the Centers for Disease Control disease stage-based (i.e., primary, secondary, tertiary) and the National Academy of Medicine target-based (indicated, selective, universal) frameworks, and the NIA Health Disparities Research Framework. Mass-ENVISION will collaborate closely with other NIA-funded Centers and their investigators, including the Massachusetts Alzheimer’s Disease Research Center (MADRC), Boston University ADRC (BU-ADRC) and Boston Claude D. Pepper Older Americans Independence Center, to translate biological and epidemiological advances as mechanistic targets for ADRD behavioral interventions. Mass-ENVISION will be led by a PI, Dr. Okereke (Director, MGH Geriatric Psychiatry ), with strong collaborative track records with team members and Core Leads/Co-Leads, who have complementary expertise in ADRD and health disparities research, social and behavioral health, behavioral interventions, implementation science, and interdisciplinary science. Mass-ENVISION will have 4 Cores: Leadership and Administrative, Research Education Component, Data and Analysis, and Community Liaison and Recruitment. Cores will be composed of investigators with a variety of institutional affiliations in MA and Greater Boston, disciplines, and research and training skills, to facilitate Mass-ENVISION’s success in developing an effective research mentoring environment and an expanded biomedical research workforce focused on ADRD behavioral health and interventions.

Public health relevance
The Scientific Theme of Mass-ENVISION is the developing, testing and implementing of scientifically rigorous behavioral health interventions for persons with ADRD and their care partners in hospital and community settings. Mass- ENVISION investigators feature a broad range of scientific and professional disciplines, and research and training skills, to facilitate an effective mentoring environment and success in developing an expanded biomedical research workforce focused on ADRD behavioral health and interventions. We have strong collaborative track records and complementary expertise in ADRD, behavioral health and interventiions, health disparities, and interdisciplinary science.